Identification and molecular characterization of somatic mutations in MCD

PROJECT SUMMARY
Genetic mutations causing disease may be inherited, newly acquired in parental gametes and present in the
zygote, or acquired at some point in development after fertilization. The burden and localization of a post-
zygotically acquired mutation depends on when the mutation arises. Malformations of cortical development
(MCD) are a group of disorders characterized by a range of morphological and structural abnormalities of the
cerebral cortex reflecting errors in embryonic cortical development. MCD are associated with refractory
epilepsy as well as intellectual disability and may require the surgical removal of the affected tissue for seizure
control. There is increasing recognition that post-zygotically acquired somatic mutations occurring in neuroglial
progenitor cells can result in a cortical brain malformation. In the previous funding period of this grant, we
made significant progress identifying and molecularly characterizing a series of pathogenic post-zygotically
acquired somatic variants in the resected brain tissue of individuals with an epilepsy-associated cortical brain
malformation. Most notably we identified and functionally characterized the first gene associated with focal
cortical dysplasia type I, SLC35A2, and made significant advancements in the understanding of the somatic
genetic landscape across MCD. The overarching objective for the next funding cycle is to continue to identify
somatic variants across MCD and to functionally characterize the effects of novel variants associated with
different types of MCD on cortical development. In Aim 1, we will continue to collect resected brain tissue
specimens from individuals with MCD for high-depth exome or targeted gene sequencing. The goal of Aim 1 is
to identify novel genes involved in MCD and to ascertain the subset of exome-negative cases for use in Aim 2.
In Aim 2, we will use highly sensitive duplex sequencing to detect very low-level somatic variants and PCR-free
whole-genome sequencing to detect somatic short tandem repeat variants and intermediately sized somatic
copy number variants in exome-negative MCD cases. The goal of Aim 2 is to determine the contribution of
these classes of somatic variants that are routinely missed due to the limitations of standard short-read exome
sequencing in the overall somatic genetic risk of MCD. Finally, Aim 3 will evaluate the functional consequences
of knocking out newly identified MCD genes harboring somatic loss-of-function variants on neuronal
morphology, neuronal migration, and ultimately cerebral cortical development in the developing mouse brain.
These studies will: (i) continue our in-depth assessment of the role of somatic mutations across MCD
subtypes, (ii) identify novel genes/pathways involved in cortical development, (iii) use complementary in vitro,
ex vivo, and in vivo models to understand the role of novel genes implicated cortical development, and (iv)
establish biomarkers and platforms that can be used in the future for screening of compounds to possibly
prevent or improve the prognosis of MCD.

Public health relevance
PUBLIC HEALTH RELEVANCE Brain malformations that occur during human fetal development commonly lead to severe epilepsy and intellectual disability. In this study, we seek to identify the genetic bases of common subtypes of brain malformations and to determine the role of implicated genes on brain development in vivo and in vitro. This work will evaluate the role of somatic variants in brain malformations, improve the understanding of the genes and processes involved in brain development, and will begin to illuminate strategies for early detection and treatment options for patients suffering from these and related conditions.